Dissecting the mechanisms of how MYH7 S2 mutations lead to genetic hypertrophic cardiomyopathy

Familial hypertrophic cardiomyopathy (HCM) is a genetic cardiomyopathy affecting 1 in 500 US adults.1,2
Mutation in myosin heavy chain seven (MYH7), a sarcomeric thick filament protein, accounts for 20-40% of HCM
cases.3,4 However, current understanding lacks a generalizable mechanism through which specific MYH7
variants result in HCM, and no specific disease-modifying therapy exists.5 The MYH7 S2 domain, host to
numerous identified pathogenic variants, interacts with the C1C2 domain of cardiac myosin binding protein C
(cMyBP-C).6 We have generated hiPSC-derived cardiomyocytes (hiPSC-CMs) from an HCM patient with MYH7
variant E848G. Our preliminary data suggest E848G disrupts the S2/C1C2 interaction and reduces MYH7
abundance. Thus, my central hypothesis is pathogenic MYH7 S2 variants that disrupt S2/C1C2 interaction
and reduce MYH7 protein abundance result in contractile function; restoration of S2/C1C2 interaction
(Aim 1) or MYH7 abundance (Aim 2) may improve contractile function. My specific aims are to: (1)
demonstrate disruption of MYH7 S2/C1C2 interaction results in contractile dysfunction; and (2) elucidate the
mechanism of E848G-induced loss of MYH7 protein abundance and test whether restoring normal MYH7 protein
abundance can rescue contractile function. I will generate pathogenic MYH7 S2 variants with CRISPR/Cas9 for
use in a mammalian two-hybrid approach to quantify dysfunction of the S2/C1C2 interaction. I will restore
S2/C1C2 interaction disrupted by pathogenic MYH7 S2 variant by targeted mutation of the complementary amino
acid in C1C2, ideally recovering contractile function in corresponding engineered heart tissues (EHTs). These
findings will be applied to MYH7 S2 variants of unknown significance to test for S2/C1C2 integrity and verify in
hiPSC-CMs. This aim will establish a novel rapid method to functionally reclassify MYH7 S2 variants of unknown
significance. In the second aim, I will characterize hypocontractility in EHTs derived from MYH7-E848G hiPSC-
CMs and correlate with observed loss in MYH7 protein abundance. I will use fluorescent recovery after
photobleaching (FRAP) to capture the dynamics of MYH7 cycling in sarcomeres with and without the E848G
variant. Overexpression of MYH7 and silencing of the mutant allele will test the relationship between MYH7
abundance and contractile function. These findings will then be corroborated in other MYH7 pathogenic variants.
This aim will establish a generalizable mechanism through which MYH7 variants lose MYH7 protein abundance
and consequently lose contractile function. In sum, these experiments will enable diagnostic tools for predicting
pathogenicity of MYH7 S2 variants and therapeutic approaches to address contractile function. This project will
take place in the highly supportive and collaborative environment of the University of Washington Department of
Medicine. With the mentorship of my Sponsor and Co-Sponsor (Dr. Daniel Yang and Dr. Charles E. Murry,
respectively), this project will provide the training required for me to realize my goal of establishing an
independent research laboratory at the crossroads of cellular biology, tissue engineering, and clinical application.

Public health relevance
PROJECT NARRATIVE Familial hypertrophic cardiomyopathy (HCM) is a common genetic cardiomyopathy that leads to heart failure, but no specific disease-modifying therapy exists, even in cases with confirmed pathogenic variants. Breakthroughs in understanding of underlying mechanism are necessary to develop new therapies for treating HCM and new diagnostic tools to predict HCM risk and severity. In this proposal, I will use patient-derived induced pluripotent stem cells to interrogate mechanisms through which pathogenic myosin heavy chain-7 variants induce contractile dysfunction to increase our understanding of HCM’s pathogenesis and enable novel therapeutic and diagnostic approaches.